Program Planning and Evaluation

Planning and Evaluation The progress of the JCCC over the last CCSG funding period, as documented in the renewal application, attests to the effective use of both internal and external planning and advisors. Overall planning and evaluation for the JCCC is conducted through the processes and committees described at length in the Organizational Capabilities section. Standing internal advisory committees include the Director's Council, the Basic and Clinical Seed Grant Review Committees, the Director's Administrative Review Committee, the Membership Committee and a variety of ad hoc groups used to review different aspects of the JCCC. During the current cycle and in addition to regular EAB Meetings, we have conducted reviews of our Office of Regulatory Compliance (3), Administration (2), fiscal affairs through an internal audit (1) and internal surveys. These planning and evaluation processes are documented and full reports are available to reviewers.